Rare Diseases Clinical Research Consortia (RDCRC) for the Rare Diseases Clinical Research Network (RDCRN) (U54 Clinical Trial Optional)

OVERALL ABSTRACT
Urea Cycle Disorders (UCD) comprise a group of rare inborn errors of metabolism that historically have been
associated with a rate of mortality and morbidity that once was considered intractably high. The Rare Diseases
Clinical Research Consortium in Urea Cycle Disorders (UCDC) has enjoyed success in attenuating and even
reversing this lamentable situation. The UCDC focuses on the 8 related disorders that involve deficiencies in one
of the 6 enzymes and 2 membrane transporters essential for urea biosynthesis: N-acetylglutamate synthase
deficiency; Carbamyl phosphate synthase I deficiency; Ornithine transcarbamylase deficiency;
Argininosuccinate synthase deficiency; Argininosuccinatelyase deficiency; Arginase deficiency (Argininemia);
Hyperornithinemia, hyperammonemia, homocitrullinuria (HHH) syndrome; and Citrullinemia type II. Over the
past 15 years the Consortium has developed into an international network of 16 academic centers (13 in the
U.S., 1 in Canada, and 2 in Europe) that provides state-of-the-art care and conducts innovative clinical research
in UCD.
In the next grant cycle the UCDC proposes four specific aims:
1) To advance our understanding of the pathophysiology of UCD through collaborative clinical research that
includes three projects: a) a longitudinal observational, “natural history” study of affected individuals with an
expanded focus on mining the wealth of coded clinical data to uncover new morbidities in UCD; b) a clinical
study to understand the consequences of seizure activity and define potential neuroprotective treatment
approaches during hyperammonemic crises; and c) an observational study of the development of liver
dysfunction and disorder over time in individuals with UCD, including defining biomarkers of hepatic fibrosis.
2) To nurture the development of the next generation of rare disease researchers by training this still-
nascent cadre to become expert in the performance of team science clinical investigation of rare genetic
disorders, especially UCD.
3) To identify promising new approaches to UCD care by performing pilot/feasibility clinical research projects
that will deploy state-of-the-art methodologies and technology to monitor and track patients in the clinic and with
deployment of technologies to enable remote observation.
4) To disseminate knowledge and improve the care of UCD by providing ready access to information for all
individuals whose efforts will impact outcome, including researchers (both basic and clinical), physicians, and
allied healthcare professionals by professional meetings and listservs, our website, podcasts and webinars. Of
importance to the Consortium also will be dissemination of information to patients, families, representatives in
government and the lay public. The Consortium will execute this informational role through the UCDC’s annual
newsletter, public website, presentations at conferences, and publications.

Public health relevance
OVERALL PROJECT NARATIVE We anticipate that the results of our studies will be a marked improvement in the outcome of patients with UCD through the development of new therapies and improved clinical management through evidenced based medicine. Furthermore, an improved understanding of the pathogenesis and treatment of UCD is likely to advance our understanding of more common disorders of liver dysfunction.